ACE2 SARS-CoV2-mediated valve disease in a microphysiological tissue-chip model

PROJECT SUMMARY
Recent reports have uncovered the role of angiotensin-converting enzyme 2 (ACE2) as the receptor for
mediating severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) entry into host cells. The aortic valve
is one specific tissue within the cardiovascular system that has robust expression of ACE2 and other renin-
angiotensin system (RAS) mediators. However, there are no studies that test if ACE2 or RAS expression in the
aortic valve increases the propensity for its robust infection by SARS-CoV-2. We also do not know if SARS-CoV-
2 infection probability increases if there is existing valve pathology in the patient. We hypothesize that altered
ACE2 expression and RAS signaling during calcific aortic valve disease (CAVD) progression potentiates
increased susceptibility to SARS-CoV-2 infection, and thereby further progression of valve pathology. This
hypothesis will be tested via the following three specific aims: Aim 1 focuses on studying the expression profile
of ACE2 and RAS signaling molecules at various stages of valve disease in human ex vivo valve sections. Aim
2 seeks to engineer and validate a three-dimensional human aortic valve tissue-chip that can mimic normal
(healthy) and diseased aortic valve leaflets. Aim 3 will test the ACE2-mediated effects of SARS-CoV-2 infection
on these valve-chip models to understand if valve pathological burden predisposes the valve to more severe
SARS-CoV-2 infection. We will also test the efficacy of ACE2 blockade as a potential therapeutic strategy. If the
proposed experiments are successful, this R15 grant will set the stage for future larger-scale preclinical testing
studies using our valve-chip to study the pathological effects of SARS-CoV-2 infection on the cardiovascular and
valve systems. The proposed studies are also intertwined with a robust research exposure plan for providing
meritorious research experiences to undergraduate students, with exposure to clinical perspectives via our
clinical collaborator Dr. Vallurupalli. We will draw from the diverse pool of undergraduates available at the
University of Arkansas, a minority-serving institution as designated by the Department of Education, including
students underrepresented in the biomedical research workforce.

Public health relevance
PROJECT NARRATIVE In this proposal, we seek to develop a novel aortic valve tissue-chip to study the effect of severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) infection on the aortic valve. We will also ask if existing aortic valve disease predisposes the tissue to a more severe SARS-CoV-2 infection and downstream pathology. Our approach will thus have significant clinical impact in the treatment of aortic valve infection in coronavirus disease 2019 (COVID-19) patients.